TRIAL TO EVALUATE ACTIVITY OF 141W94 IN PATIENTS WITH HIV INFECTION

A Phase I trial to evaluate the safety, pharmacokinetics and antiviral acctivity of 141W94 after multiple dosing in patients with HIV infection.